2015 AAOS/ORS Biologic Treatments of Orthopaedic Injuries Research Symposium

? DESCRIPTION (provided by applicant): The 2015 AAOS Biologic Treatments for Orthopaedic Injuries (BTOI) research symposium will provide a forum for discussion and collaboration among a multidisciplinary group of basic scientists, clinicians, young investigators, [and registrants] t develop a consensus and identify ways to improve strategies for translational pathways to link current cutting edge biological research to the clinical application of biologic treatments for musculoskeletal injuries Through targeted breakout discussions, program participants and young investigators will exchange information to stimulate new research opportunities and highlight areas of specific needs for improving patient care. Specifically, the BTOI symposium will examine current standards and identify knowledge gaps for the use of autologous blood products such as platelet rich plasma (PRP), the use of minimally manipulated adult progenitor cells, as well as the use of scaffold-based strategies of the repair, reconstruction, and/or regeneration of tendon, ligament, muscle, and articular cartilage tissues. The symposium proceedings will be published and widely disseminated in a relevant orthopaedic journal. An emphasis will placed on mentorship and the establishment of research collaborations and funding opportunities for [up to 15] young investigators (academic orthopaedic clinicians and basic scientists) in a small meeting format [(young investigators will be approximately 20% of total meeting attendees)], including full travel support, with the expectation that the young investigators will present their research to leaders in the field, and networking discussions [to expose the young investigators to leaders in their field].

Public health relevance
PUBLIC HEALTH RELEVANCE: The 2015 AAOS/ORS Biologic Treatments for Orthopaedic Injuries (BTOI) research symposium will review the current state of the art and identify knowledge gaps in emerging biologic treatments for articular cartilage, muscle, tendon, and bone injuries. With the ultimate goal of translating current bench research to accelerated and directly measurable improvements [and patient based outcomes in] patient care, the BTOI symposium will provide a forum for discussion and collaboration among a multidisciplinary group of basic scientists, clinicians, and young investigators to develop a consensus and identify ways to improve strategies for translational and clinical application of biologic treatmens for musculoskeletal injuries.